Addressing bone marrow lesions that compromise osteochondral tissue repair

ABSTRACT
Degenerative joint diseases such as osteoarthritis (OA) remain the source of significant pain and disability,
affecting over 30 million adults with an annual US economic burden of more than $486 billion. Joint replacement
is a well-established procedure, but its finite life span makes this treatment unacceptable for younger (under 65)
or more active individuals. For this growing patient population, Cytex is developing implants pairing a patented
3D weaving technology with additive manufacturing to facilitate cartilage and bone regeneration. The implant is
designed to support joint loading immediately upon implantation and to allow integration and development of
osteochondral tissue. Other cartilage repair treatments have promising clinical results, but can lead to the
formation of fibrous tissue, apoptosis, and further cartilage degeneration. Further, in the knee, subchondral bone
marrow cysts, bone marrow lesions (BML), and edema commonly undermine cartilage repair, with iatrogenic
damage to the subchondral bone resulting in considerable and complex issues for long-term clinical outcomes
from the repair procedure. Cytex implants have demonstrated the capability of repairing osteochondral lesions
and restoring pain-free joint function for extended durations in large animal models of hip OA. Conversely, in the
knee joint, we have routinely observed significant BMLs that result in graft failure. The ingress of synovial fluid
with pro-inflammatory cytokines into the bone is a proposed mechanism for BML formation. Based on this
mechanism, we established an animal model of BMLs alongside imaging optimization for detection of BMLs.
The objective of the current proposal is to develop and test an acellular implant specific to cartilage repair in the
knee and other joints where BMLs are common. We hypothesize that reducing implant permeability at the time
of implantation will prevent the ingress of synovial fluid into the bone cavity and prevent BMLs, allowing the
implant to restore joint congruity. Building on our pilot work, we will incorporate crosslinked hyaluronic acid (HA)
gels into our 3D woven textile. These HA gels have shown relative impermeability and limited inflammatory
response in vivo. We will select an optimized gel based on sustained relative impermeability while allowing for
significant in vitro gel degradation over 8 weeks. In an in vivo study, the resulting HA-gel implants will be
compared against an unmodified acellular implant (permeable control) and microfracture (“standard of care”
control) with success criteria based on BML severity, OA severity, and implant functional characteristics
(mechanical properties and cartilage repair). Forming a temporary biological barrier in the textile component of
our implant should prevent the formation of a BML while also ensuring the ability of the Cytex implant to repair
and regenerate the damaged cartilage in the knee.

Public health relevance
NARRATIVE The purpose of this project is to develop an implant for osteochondral knee repair that prevents the formation of bone marrow lesions, a common complication that can lead to implant failure. This will enable Cytex to reliably use its cartilage repair technology in the knee and other joints, providing a solution to painful cartilage pathology for patients who need surgical intervention but are too young or active for a joint replacement. The Cytex implant is designed to mimic the characteristics of cartilage, provide immediate mechanical support for the activities of daily living, relieve pain, and regenerate natural tissues long-term.